Administrative Supplement: The ASCEND (Advancing Skills in Contracting and Execution for NIH-Designated Grants) Initiative

PROJECT SUMMARY/ABSTRACT
Low- and middle-income countries (LMICs) in Sub-Saharan Africa are playing an
increasingly prominent role in NIH-funded cancer prevention and control research. However,
these institutions often lack the administrative infrastructure necessary to manage the full life
cycle of NIH grants, including pre-award budgeting, post-award compliance, subrecipient
monitoring, and audit readiness. These gaps threaten the sustainability and efficiency of global
cancer research collaborations. In response to NIH policy guidance (NOT-OD-25-104) and in
alignment with PA-20-272, this administrative supplement expands the scope of the Winship
Cancer Institute’s NCI-designated Cancer Center Support Grant (P30CA138292) to address
these critical capacity deficits.
This initiative will develop and implement a scalable, hybrid training and mentorship
program to strengthen research administration capabilities at LMIC institutions. The program will
be anchored at Emory University’s Winship Cancer Institute and Rollins School of Public Health
and co-developed with experienced administrators from Sub-Saharan Africa. Specific Aim 1 will
create an interactive, modular online curriculum tailored to NIH requirements and LMIC
institutional contexts. Specific Aim 2 will train a cohort of LMIC-based research administrators
using a structured, three-phase “train-the-trainer” model that includes online coursework,
professional certification through the Society of Research Administrators International (SRAI),
and on-site mentored training at Emory. Specific Aim 3 will pilot and evaluate the training
cascade with a larger cohort of LMIC administrators in Sub-Saharan Africa, including a 2-day in-
person workshop, knowledge assessments, peer mentorship, and post-training follow-up.
The training model will be guided by the Kirkpatrick evaluation framework to assess
satisfaction, knowledge gains, behavioral intention, and institutional outcomes. Outputs will
include a best practices toolkit, standardized SOP templates, and freely available training
materials to support scale-up and dissemination. By investing in the research administration
workforce, this project promotes sustainable infrastructure for global cancer control, enhances
compliance with NIH policies, and advances equitable research partnerships between U.S. and
LMIC institutions.

Public health relevance
Project Narrative This project addresses a critical barrier to global cancer research by strengthening grants administration capacity in low- and middle-income countries (LMICs). Through a hybrid, scalable training and mentorship model anchored at Emory University’s Winship Cancer Institute, the program equips LMIC institutions with the tools to meet NIH requirements for financial oversight, compliance, and sustainability. By enhancing administrative infrastructure, the initiative supports the long-term success of NIH-funded cancer control efforts and fosters equitable international research partnerships.